Multinuclear imaging for clinical 7T MRI

PROJECT SUMMARY
This application requests funding to upgrade a whole-body 7T MR human clinical scanner (Tera system by
Siemens Medical Solutions USA, Inc.) with advanced multi-nuclear option (MNO). The proposed upgrade will
enable MR imaging and spectroscopy of non-proton nuclei such as 2H, 3He, 7Li, 13C, 17O, 19F, 23Na, 31P,
and 129Xe, for clinical research on patients and healthy volunteers, as well as animal models of disease. Our
users and others have shown that multi-nuclear MR probes important molecular mechanisms in cancer,
neurological, and psychiatric diseases, which cannot be probed by other means. This advanced hardware will
enable innovative, accelerated, multinuclear-multimodal metabolic and molecular imaging to be performed in
one imaging setting. The proposed multinuclear MR system will be an invaluable and unique resource for the
rich translational research at the MGH Martinos Center and at other institutions in Boston.
The proposed upgrade of the whole-body 7T MR for advanced multi-nuclear imaging will meet the Institution’s
dual mission of technology development and translational research. The proposed 32 receive channels will allow
innovative multi-array coil designs for multi-nuclear MR imaging with high resolution and speeding up
the acquisition by tenfold. The plug-and-play ready feature will enable the utilization and sharing of innovative
multi-nuclear imaging techniques in multi-center trials. As these innovative technologies move into the
clinic, new insights into human disease will likely be forthcoming with this exciting multi-nuclear upgrade which
will benefit a large number of investigators and patients for years to come.
The proposed multi-nuclear MR system will be located within the MGH Martinos Center, which operates as a
NCRR-funded National Research Resource, supplying state-of-the-art molecular imaging instrumentation and
services to MGH and the broader research community nationwide. The Martinos Center has a renowned
molecular imaging program, consistently producing successes with every new modality that has been
incorporated into our program, such as MRI, MEG, EEG, PET, Nano-particle MRI and Optical Imaging. With the
same rigor and dedication, we anticipate the successful development of an advanced multi-nuclear and multi-
modal metabolic imaging program with support from NIH for the proposed instrument.

Public health relevance
PROJECT NARRATIVE The proposed instrumentation is an upgrade of a whole-body 7T MR human clinical scanner with a state-of-the- art multi-nuclear MR system (MNO, Siemens Medical Solutions USA, Inc.), comprising hardware and software to allow MR spectroscopy and imaging to be performed on the frequency bands of the nuclei 2H, 3He, 7Li, 13C, 17O, 19F, 23Na, 31P, and 129Xe. Multi-nuclear MR has been shown by us and others to provide new understanding of human health and disease mechanisms at the molecular level, which other imaging cannot offer. The advanced hardware and a unique plug-and-play feature will enable innovative, accelerated multinuclear-multimodal molecular and metabolic imaging. This will be a unique key shared resource for researchers within the Institution and the research communities in the greater Boston area, performing clinical research in cancer, neurological and psychiatric diseases.